Characterizing migratory cell differentiation in developing zebrafish skin

Abstract
Mature cell types must be properly differentiated and distributed in tissues during development in all organisms,
including humans. Some examples of cells that are broadly distributed include mucus cells (also called goblet
cells) and ionocytes, which populate many human mucosal tissues, including the lung. Mucus cells produce
mucus to lubricate and protect the epithelial surface; ionocytes regulate the ion balance on either side of the
epithelial barrier. Dysregulation of either of these cell types causes severe human disease in many organ
systems. Analogous cell types are also found in embryonic zebrafish skin, a highly tractable model system in
which live imaging can be easily used to study development. This proposal will characterize the development of
recently discovered intraepithelial migratory cells in embryonic zebrafish skin that are precursors to mucus cells
and ionocytes, dissecting their mechanism of migration as well as the gene expression patterns responsible for
their differentiation. The Sagasti lab has found that these cells derive from stem-like tp63+ basal cells in zebrafish
skin during the first day of development, migrate between the basal and periderm layers of skin throughout the
body for several hours, and eventually halt and intercalate into the periderm, where they become differentiated
mucus cells or ionocytes. We propose that this process functions to spatially distribute mature ionocytes and
mucus cells throughout the skin and may be conserved in human mucosal tissues.
In this proposal, I will use live imaging and antibody staining to determine whether these migratory cells exhibit
mechanisms of amoeboid or mesenchymal migration, as well as pharmacologic and genetic inhibitions to
functionally characterize these pathways. Additionally, I will use single-cell RNA sequencing and pseudotime
analysis to describe the process by which these cells differentiate into mature cell types and generate candidate
genes that are involved in migration. Finally, I will use a CRISPR screen to find genes that are required for
migratory cell motility and distribution, and create knockout lines for future study. Taken together, this project will
investigate a method of simultaneous cell migration and differentiation within a developing epithelial tissue,
resulting in the proper distribution of mature cells.
My training goal is to be an independent investigator in the field of skin developmental biology. The proposed
fellowship training is an important step towards this career. The research proposed here will give me an excellent
background in zebrafish research and epithelial development, training me in impactful techniques, including live
imaging, genetic manipulation, and bioinformatics. Further, my training plan includes the IRACDA program at
UCLA, which will train me in teaching pedagogy and provide experience designing and delivering lectures at
CSULA under the mentorship of experienced professors. This experience will prepare me for the multifaceted
career of a principal investigator by gaining experience with zebrafish epithelial research, teaching, and
mentorship.

Public health relevance
Project Narrative Mucus cells and ionocytes are crucial to the function of many organs and are conserved across animals including humans and zebrafish. Impairment of mucus cell and ionocyte function can cause human disease, including contributing to cystic fibrosis, but despite the importance of these cell types, it is poorly understood how they are distributed throughout the mature tissue during development. In this proposal, I will use zebrafish skin as a model system to dissect the mechanisms by which mucus cell and ionocyte precursors simultaneously migrate through an epithelial tissue and differentiate into their mature forms, revealing potential avenues for further study of human mucosal tissue diseases.